Curation and Informatics Component

Project Summary – Curation Component
This project supports new funding for the National Xenopus Resource (NXR) as part of the Curation and
Informatics Component. In this new component we propose to establish improved curation of the 400 strains in
the NXR and closer cooperation with Xenbase to ensure that all our information is readily available to the wider
Xenopus community. We will also enhance the NXR website to make it more user friendly and accessible.